Linking insufficient sleep with body weight in Black emerging adults.

PROJECT ABSTRACT
Compared to peers in other racial groups, Black emerging adults (18-28 years old) have the highest risks of
short sleep duration and cardiovascular disease. This increased risk may be partly explained by greater stress
levels resulting from race-related stress (experiences of racial discrimination and heightened feelings of
vigilance). Insufficient sleep (longer sleep-onset latency, shorter sleep duration, poorer sleep quality and
efficiency, lower amounts of slow-wave sleep) may also lead to greater arterial stiffness (hardening of the
arteries, reducing their elasticity and ability to expand and contract as blood is pumped through them) and
unfavorable hemodynamic characteristics (physical factors such as high blood pressure, pulse pressure, mean
arterial pressure, and heart rate that govern blood flood and heart function), which are well-known risk factors
for cardiovascular disease. This supplemental project aims to examine cross-sectional associations between
measures of insufficient sleep and race-related stress with arterial stiffness and central hemodynamics in 55
Black emerging adults. The parent R01 grant follows a measurement burst design that includes data collection
over 3 bursts (baseline, 6-month follow-up and 12-month follow-up), each lasting 7 days. Measures of arterial
stiffness and central hemodynamics will be added to the Day 5, in-laboratory protocol prior to measures of resting
energy expenditure. Measures of arterial stiffness (via carotid-femoral pulse wave velocity) and central
hemodynamics (via pulse wave analysis) will be captured with the SphygmoCor XCEL system. Insufficient sleep
variables will be measured with three methods: sleep diary, actigraphy and polysomnography. Race-related
stress will be self-reported. Aim 1 will examine cross-sectional associations between insufficient sleep with
arterial stiffness and central hemodynamics. Aim 2 will examine cross-sectional associations between race-
related stress with arterial stiffness and central hemodynamics. Our overarching hypothesis is that higher
amounts of insufficient sleep and race-related stress will be associated with higher arterial stiffness and
unfavorable hemodynamic characteristics. This proposed supplemental project is a logical extension of the goals
of the parent grant by adding a clinically relevant outcome (measures of arterial stiffness and central
hemodynamics) to the parent R01 project which focuses on sleep, race-related stress, and obesity risk. This
proposed supplemental project could also have significant public health implications by investigating initial
associations between sleep, race-related stress, and well-known risk factors for cardiovascular disease in Black
emerging adults.

Public health relevance
PROJECT NARRATIVE Black emerging adults (ages 18-28 years) have the highest risks of insufficient sleep and cardiovascular disease, but little is known about how and why these disparities exist. Our project will examine associations between measures of insufficient sleep and race-related stress with measures of arterial stiffness and central hemodynamics (well-known risk factors for cardiovascular disease) in Black emerging adults. By focusing on emerging adulthood – when many individuals establish and solidify lifelong sleep and health behaviors – this project will take an essential first step towards understanding the role of sleep and race-related stress in shaping cardiovascular disease risk in Black adults.